PRODUCTION, ANALYSIS, AND DISTRIBUTION OF CANNABIS AND RELATED MATERIALS. POP: MARCH 23, 2015 - MARCH 22, 2023. N01DA-15-7793.

The primary purpose of this contract is to provide materials to support research on marijuana (cannabis) and its constituents.